RESTORATION OF GH SECRETION IN OBESE MEN BY PULSATILE ADMINISTRATION OF GHRH

The low plasma growth hormone concentrations observed in healthy obese men can be reversed by the pulsatile administration of hypothalamic GH-releasing hormone.